Aberrations in oligodendrocyte development resulting from congenital heart disease and its surgical treatment

? DESCRIPTION (provided by applicant): Delayed brain development and white matter (WM) injury are common in neonates with congenital heart disease (CHD) at the time of birth. Both have been documented by clinical MRI studies. New WM injury is also common in these same individuals with CHD following neonatal cardiac surgery, most likely secondary to the deleterious effects of cardiopulmonary bypass (CPB). New WM injury is more likely to be seen in the immature brain resulting from CHD-induced in utero hypoxia. However, cellular mechanisms underlying delayed maturation and WM injury in CHD and effects of CPB on immature brain remain poorly understood. Insights into these mechanisms would allow prevention and/or development of effective treatment for neonatal WM injury in patients with CHD. Previous studies have documented that in the neonatal rodent brain hypoxia and ischemia alter generation and migration of oligodendrocyte progenitor cells (OPCs). Prolonged hypoxia also delays OPC differentiation in a mouse model leading to WM hypomyelination. WM hypomyelination is one component of a clinically-applied scale for brain immaturity. Therefore, we will test the following hypotheses: i) Impairment of OPC generation and differentiation in the WM due to preoperative hypoxia results in WM hypomyelination and brain immaturity; ii) Both the inflammatory effects of CPB as well as the reperfusion and reoxygenation of circulatory arrest exacerbate the impaired generation and delayed OPC migration and maturation. The first model that will be used will be a piglet hypoxia model. Immature development of the porcine brain in this experimental paradigm is very similar to that observed in newborns with CHD. The impact of CPB on the immature brain will be investigated with a combined paradigm using piglets exposed to both hypoxia and CPB. To analyze OPC maturation in the porcine brain, we have generated OPCs derived from porcine stem/progenitor cells. Proliferation of OPCs will be measured using immunohistochemical methods. OPC migration will be continuously monitored by novel cell tracking MRI techniques using superparamagnetic iron oxide labeling in vivo. Development from OPCs to mature oligodendrocytes will be defined by fluorescent marker histology. Microstructural maturation of WM will be analyzed by serial volumetric analysis and diffusion tensor imaging. Finally correlation between microstructural maturation and brain immaturity will be defined. The proposed studies will define crucial cellular mechanisms underlying the causes of brain immaturity and WM injury in the neonate with CHD. The findings will assist decision-making regarding optimal timing and techniques of surgery. The proposed studies have the potential to identify and assess novel strategies to treat brain immaturity and WM injury, and define new standards of perinatal care in the patient with CHD. The resulting improved neurodevelopmental outcomes would be of enormous benefit to those individuals with CHD.

Public health relevance
PUBLIC HEALTH RELEVANCE: Developmental studies have demonstrated an important incidence of long-term neurological deficits and behavioral problems in children with congenital heart disease. The proposed translational animal study will investigate cellular mechanisms of prenatal and postnatal brain injury resulting from congenital heart disease and its surgical treatment. Experiments will focus on the generation, migration and maturation of oligodendrocytes that play a crucial role in brain growth during the perinatal period by laying down myelin in the white matter.